Administrative Core

Project Summary/Abstract
The overarching goal of the Administrative Core is to transform the Center’s capacity to contribute rigorous,
innovative research on climate change and health. This P20 mechanism provides the means to create the
collaborative, transdisciplinary infrastructure that will enable innovative, translational research that contributes to
health resilience of vulnerable individuals and populations in the face of climate change-associated challenges.
This Core has the following Aims: Aim 1.Coordinate and integrate C3HRC components and activities, and
actively communicate with advisory boards, members, partners, and NIH. Under this aim, the administrative core
will: a) Establish the overall center structure, leadership and partnerships and replenish these as needed; b)
Convene meetings and coordinate the C3HRC Leadership Team and advisory boards, with timely
communication of minutes to the respective stakeholders; c) Coordinate the work of the Research Teams and
our partners, enabling us to better address the C3HRC’s central theme. Aim 2. Lead the growth and
transformation of the C3HRC by recruiting members and partners, enabling collaborations, enacting our plan for
enhancing diverse perspectives (PEDP) and developing our capacity for sustainability. Under this aim, the
administrative core will: a) Cultivate transdisciplinary center membership and maintain an accessible database
to enable communication among center members and partners; b) Support member capacity for transformative
research on climate change and health through information-sharing and active development of collaborations;
c) Actively incorporate alternative perspectives by enacting our Plan for Enhancing Diverse Perspectives; and d)
Develop and enact a Plan for Center Development and Sustainability, which addresses what the C3HRC aims
to develop and achieve by the end of P20 support to attract funding and long-term success. Aim 3. Provide
effective management of the C3HRC, including utilization of funds, monitor and enable productivity, and ensure
compliance with regulatory requirements. Under this aim, this core will: a) Oversee the center budget and review
expenditure of funds monthly, assuring the timely expenditure of these funds, and identifying additional resource
needs; b) enact center-wide data management and resource sharing plans; c) assure regulatory compliance;
and d) monitor center productivity in terms of publications, grants submitted and awarded and meeting evaluation
milestones. The Administrative Core is committed to leveraging NIH and institutional resources to foster an
environment that contributes high impact research on climate-related health effects, health equity, strategies for
adaptation and resilience, and workforce development. The research environment at our institution is exceptional
and highly conducive to the development of team science and groundbreaking discoveries.